The WUSTL PREP post-bacc program to enhance doctoral readiness in neuroscience

PROJECT SUMMARY
This application would create a neuroscience training program in St. Louis (NeuroPREP) for recent
undergraduate students. The objective of the grant is to provide rigorous and critical training in neuroscience to
a diverse cohort of students taking advantage of the strong interest in neuroscience at Washington University,
the University of Missouri-St. Louis, St. Louis University and Harris-Stowe State University. By providing fully-
funded support for 2 years of independent research and an introduction to the culture of science, this proposal
will establish a pathway to graduate training in Neuroscience. NeuroPREP emphasizes sustained training in oral
and written science communication, discovery science and outreach experience. Specifically, this proposal will
support 7 early-stage trainees for two years each (3 of whom will be supported with Institutional resources).
Washington University has long-standing commitments to cutting-edge research, to interdisciplinary education,
and to providing modern career development. We seek to be a Program that responds to changes in the research
environment by helping our students to pursue important and innovative problems and concepts, to adopt new
techniques and to communicate effectively with their peers and the general public. The potential research
environment is organized as a Training Faculty of 54 active scientists who study fundamental questions in basic
and clinical neuroscience. The 54 faculty represent 16 different Departments in three different Schools at
Washington University (Arts & Sciences, Medicine, Engineering). Each faculty mentor directs a well-funded
research program and is deeply committed to provide a positive learning experience and welcoming work
environment. The curriculum for education will likewise present a broad and deep introduction to molecular,
cellular and systems-level approaches to the study of neural function and dysfunction. It will organize dedicated
courses, but also offer optional involvement in existing undergraduate and graduate coursework. The Program
will recruit and retain talented, diverse students through innovative and dedicated coordination with the University
and partner schools and be evaluated formally by an Executive Advisory Board of Directors. Major new initiatives
aimed at accomplishing these goals include: 1) creation of a local network of educators across many Schools to
identify candidates and foster the program for the benefit of the region; 2) the introduction of two interactive
courses to bolster neuroscience fundamentals and a sense of community among the students (Critical Thinking
in Neuroscience & Professional Skills for a Neuroscientist), 3) involvement of the students in the Society for
Neuroscience Brain Bee as part of their training in science communication, and 4) refinement of a near peer-
mentoring program that has graduate students working with postbaccs and postbaccs working with high school
students. These initiatives will promote our students’ education in neuroscience, and in professional skills. It will
also provide them explicit guidance in the process of graduate school applications.

Public health relevance
The Neuroscience Postbaccalaureate Research Education Program (NeuroPREP) will build regional networks of Schools to identify, recruit and foster program participation from students who did not participate in in-depth research experiences as undergraduates. After 2 years, NeuroPREP students will be fully prepared to pursue graduate training in neuroscience.